Developing a Critical Health Equity Research Agenda

Project Abstract
Many existing and emerging methodologies and methods are being utilized and developed to
understand and address multiple forms of oppression, and ultimately health inequities, yet there
are few spaces in which these are being delivered and debated. Furthermore, while
epistemology is a critical starting point for health equity research, discussions about different
epistemologies are also rare. This has all resulted in critical gaps in understanding, developing,
and implementing such important health equity research and practice solutions. For example,
there are several measures of structural racism being utilized, mostly born out of the social
sciences, yet these have not been widely integrated in the medical and public health fields. This
application requests support for an innovative one-day workshop, “Developing a Critical
Health Equity Research Agenda”, for pre- and post-doctoral trainees and scientists who
aspire to contribute to the field of health equity research through an interdisciplinary and
population science lens. The workshop leverages our longstanding partnership with the
Interdisciplinary Association for Population Health Science (IAPHS), a scientific organization
devoted to advancing population health science and its application to improving health and
reducing health disparities. IAPHS is an ideal platform for such a workshop as its members
have been engaging in discussions around racism and other forms of oppression since the
organization’s inception. The overall objective of the proposed conference grant is to bring
together researchers and community stakeholders who are considering, conducting, or have
completed studies aimed at advancing health equity and to provide an orientation to critical
health equity research methods and training in select existing and emerging methodologies. The
proposed workshop is very different from other NIMHD-supported conferences, which have not
focused on critical health equity research methodologies and solutions such as participant-
driven methods and alternative epistemologies aimed at advancing health equity research. The
workshop is expected to impact both participants and a broader community of scholars who
aspire to contribute to health and health equity research through effective interdisciplinary
research, collaboration, and practice.

Public health relevance
Project Narrative Many existing and emerging methodologies and methods are being utilized and developed to understand and address multiple forms of oppression, and ultimately health inequities, yet critical gaps remain in the understanding, developing, and implementing of such important approaches to health equity research and practice solutions. Leveraging our longstanding partnership with the Interdisciplinary Association for Population Health Science (IAPHS), the overall objective of the proposed conference is to bring together researchers and community stakeholders who are considering, conducting, or have completed studies aimed at advancing health equity and to provide an orientation to critical health equity research methods and training in select existing and emerging methodologies. The conference is expected to impact both pre- and post-doctoral trainees and scientists who aspire to contribute to health and health equity research through effective interdisciplinary research, collaboration, and practice.